Integrative Approach to Comprehensive Analysis of High Throughput Data on a Cancer Center Level

The Bioinformatics Shared Resource (BSR), supported by the Cancer Center Support Grant (CCSG) awarded to the Wistar Institute, collaborates with the vast majority of cancer center members on multiple research projects. My role as a Research Specialist and Managing Director of the BSR is to be engaged with all steps of many of those research programs. The institute-wide involvement in cancer-related studies allows me to develop comprehensive data analyses pipelines applicable across multiple programs, as well as to re-use obtained results, including databases, summarized and annotated datasets and other integrative resources, in carrying out analyses customized to particular studies. In combination with project-specific research efforts, which in turn also contribute to the existing knowledgebase, this integrative approach provides a robust scientific environment for applying methods of computational biology to various cancer-related studies as demonstrated in the application.

Public health relevance
The application is aimed to support cancer2related research efforts of The Wistar Institute investigators through computational expertise provided by Bioinformatics Shared Resource. Focus of the supported projects involve experiments on a number of cancer cell lines or primary cancers, including melanoma, ovarian, prostate, various blood cancers, lung, colon and many others. In a number of studies, genes within the project’s interest were shown to be clinically relevant in multiple cancers through analysis of clinically2relevant data and are shown to be deregulated in cancers, associated with metastasis, correlated with stage/grade/etc or significantly correlated with patient survival. There are also projects that focus on more basic mechanisms closely related to cancers: cell proliferation, apoptosis, invasion and motility, embryonic development, etc.